Biofeedback-Enhanced Treatment for Sensorimotor Learning in Speech Sound Disorders: Clinical Trial and Delineation of Subtypes

Project Summary/Abstract
Children with speech sound disorder show diminished intelligibility in spoken communication, with negative con-
sequences for both social-emotional and academic-occupational outcomes [1–4]. While most speech deviations
resolve by the late school-age years, between 2-5% of speakers exhibit residual speech sound disorder (RSSD)
that persists through adolescence or even adulthood [5–7]. Both affected children/families and speech-language
pathologists (SLPs) have highlighted the critical need for research to identify more effective forms of treatment for
children with RSSD. Our work in the previous funding cycle showed that individuals with RSSD benefit from treat-
ment incorporating technologically enhanced sensory feedback (visual-acoustic biofeedback, ultrasound biofeed-
back). However, real-world adoption of biofeedback treatment remains limited by equipment costs and lack of
access to providers with specialized training.
For our next phase of research, we focus on developing methods to support wider implementation of
technology-enhanced treatment for RSSD. Specifically, we investigate the possibility that access to biofeedback
can be expanded through telepractice service delivery and the use of Artificial Intelligence (AI)-powered technol-
ogy to extend the services provided by SLPs. At the same time, we evaluate whether the efficacy of biofeedback
can be further enhanced by adopting a precision medicine approach in which a treatment method is selected
based on a learner’s individual profile of sensory strengths and weaknesses.
In this proposal, we will conduct the first controlled comparison of biofeedback treatment delivered in person
versus via telepractice (Aim 1), testing our hypothesis that biofeedback intervention can be delivered remotely
without any unacceptable loss of efficacy. If successful, this study will greatly expand the reach of biofeedback by
making it easier for children with RSSD to connect with trained clinicians. In Aim 2, we will utilize technology de-
veloped in the previous funding cycle to assess whether the maintenance of gains achieved through biofeedback
treatment can be enhanced through AI-mediated home practice. Finally, Aim 3 will lay groundwork for a precision
medicine approach by testing whether relative response to ultrasound and visual-acoustic biofeedback can be
predicted from a learner’s profile of sensory response across auditory and somatosensory domains.
While new technologies have the potential to revolutionize the development and delivery of interventions for
speech disorders, there is an ongoing need for well-designed research studies to bring these advances into
evidence-based clinical practice. This research will address the needs of children with RSSD and the clinicians
who treat them by providing a robust evidence base to guide clinical decision-making and user-friendly tools that
support implementation.

Public health relevance
Project Narrative New technologies have the potential to transform interventions for speech sound disorder, a high-prevalence condition that negatively impacts social and academic participation, but there is a lack of rigorous evidence to substantiate this promise. This research will meet a public health need by systematically evaluating the efficacy of visual-acoustic biofeedback intervention delivered in-person versus via telepractice and assessing the potential for maintenance of treatment gains to be enhanced through home practice with artificial intelligence (AI)-mediated feedback. It will also test the hypothesis that the efficacy of intervention can be optimized when the choice of biofeedback technology is personalized to match the learner’s profile of sensory strengths and limitations.